Generation and analysis of new mouse models to determine novel therapeutic targets for Down syndrome-associated cognitive deficits

ABSTRACT
Alzheimer’s disease (AD) is one of the most important challenges of our time in the field of medicine because
of its severe clinical impacts on a very large patient population and the lack of effective treatments at present. In
the United States, AD currently affects approximately 5.8 million people with an estimated annual cost of care of
$321 billion. By 2060, the number of AD cases is predicted to rise to 14 million people with an annual cost of
care exceeding one trillion dollars. For early onset AD, the most common cause is human trisomy 21 present in
the cells of individuals with Down syndrome (DS). The AD-associated pathological alterations are universally
present in individuals with DS by 40 years of age, and related dementia is diagnosed in this population at 56
years of age on average, with over 80% of people with DS affected by 69 years of age. To facilitate mechanistic
and therapeutic studies of AD in DS (AD-DS), the principal investigator’s laboratory has engineered a substantial
number of animal models of DS based on the evolutionary conservation between humans and mice at the
genomic, physiological, and pathological levels, by using Cre/loxP-mediated chromosome engineering. These
animal models are being studied by laboratories around the world, and one of them is triplicated for all three
mouse genomic regions orthologous to human chromosome 21. In this supplement application, we propose to
take the next critical step to further optimize the animal models for studies of AD-DS as well as to develop a
novel experimental system for screening for molecules that can be used to target AD-DS therapeutically. We will
pursue these aims by taking advantage of our recent successes, including the unique genetic reagents we have
developed. We believe that attainment of our objectives will result in unprecedented new research platforms that
will generate novel insights into the mechanisms underlying AD-DS, which in turn will facilitate the development
of effective preventive and therapeutic interventions for AD in both those with and without DS.

Public health relevance
PROJECT NARRATIVE Down syndrome is the most common cause of early-onset Alzheimer’s disease which causes major impairments in cognitive function, and presently, there are no effective therapies. In this project, we will develop and analyze (1) new animal models for Alzheimer’s disease in Down syndrome, which will better mimic the genetic alterations associated with this medical condition, and (2) a novel experimental system that can be used for identifying molecules that may hold promise as future therapeutic targets. The success of our project is expected to open up new avenues for the scientific community to study the molecular mechanisms underlying this devastating disease and use those newly generated insights to develop both preventive and therapeutic strategies for dealing with Alzheimer’s disease in Down syndrome as well as Alzheimer’s disease and related dementias in the general population.